Evaluation of a Mobile Application for Patients and Clinical Decision-making Support Tools for Prescribers to Decrease Opioid Misuse and Habit-forming Behaviors Following Post-operative Prescription

PROJECT SUMMARY/ABSTRACT
Opioid misuse is an epidemic and a public health crisis. At least 2 million people have an opioid use
disorder (OUD) involving prescription opioids, and 600,000 have heroin OUD6. Alarmingly, 80% of heroin users
used prescription opioids before transitioning to heroin7. It is therefore critical to ensure that opioid pain
therapies are administered safely, in a way that minimizes the potential for aberrant drug related behaviors.
This necessitates individualized opioid regimens and strict adherence, enabling effective pain control without
producing euphoria or withdrawals, both of which can lead to drug seeking behaviors. Continuous Precision
Medicine (CPM) aims to develop a software ecosystem to reduce opioid misuse and over-prescription
in postoperative patients. In a self-funded Phase I, we have developed clinical decision support software,
which consists of a server for data management and analytics and a mobile client application for the patient.
The digital platform delivers a personalized schedule, records dosing and pain levels, and motivates
adherence to dosing by scoring compliance. In this project, we propose to evaluate and improve the CPM suite
of clinical decision support tools and provide clinicians and patients with immediately actionable information to
decrease over-prescription and misuse of opioids during the post-operative period. In the proposed Phase II
SBIR project, CPM will refine and evaluate the mobile application, deploy and test a Prescriber Portal with
dashboard functions to enable physicians to overlay pharmacokinetic and pharmacodynamic modeling to
improve prescribing practices and deter drug-habit-forming behavior, and prepare materials for a 501(k)
application submission. The CPM app, patient data, and provider portal, taken together and optimally
employed to improve patient-provider communication and treatment planning, has the potential to prevent
negative sequelae associated with over-prescription and misuse of opioids, including opioid use
disorder, overdose, and death.

Public health relevance
PROJECT NARRATIVE Managing the use of opioids in the postoperative period is an essential point of intervention in combating the opioid crisis. Safe and effective pain management using opioids requires personalized dosing regimens and medication adherence. Continuous Precision Medicine (CPM) has developed a clinical decision software platform that combines analytical server software with a cloud-connected mobile digital platform, to enable individualized opioid treatments with pharmacodynamics (PD; i.e., the study of how a drug affects an organism) and pharmacokinetics (PK; i.e., the study of how the organism affects the drug) modeling, and to improve adherence by engaging the patient.